The Role of Checkpoint inhibitors in CIA

Abstract
Immune related adverse events linked to severe inflammatory arthritis have been identified in 10-43% of patients
receiving immune checkpoint inhibitors, αCTLA4, αPD-1 or αPD-L1, indicating the importance of immune
inhibitory pathways in maintaining homeostasis in the joints. We obtained human synovial fluid and found a high
frequency of PD-L1 expression by synovial macrophages. We propose to examine the role of PD-L1 expression
in synovial macrophages and T cells during murine collagen induced arthritis (CIA). We found that immune
checkpoint inhibitor, PD-L1, is primarily expressed in the joint compared to other immune checkpoints.
Additionally, we found synovial macrophages and CD3+ T cells are the main PD-L1 expressing cells in the joint,
and PD-L1 expression is increased during CIA. We extensively profiled the synovial macrophages and found
three populations of PD-L1 expressing cells: F4/80intCD115+CCR2-MHCII-CD73-Tim4-PD-L1hi (CD115+
macrophages), F4/80hiCD115-CCR2intMHCIIhiCD73intTim4intPD-L1int (MHCII+ macrophages), and F4/80intCD115-
CCR2lowMHCII-CD73loTim4intPD-L1int (F4/80+ macrophages). We have also found that PD-L1 has the highest
frequency of expression in CD4+ and CD8+ T cells. Furthermore, we identified a novel subset of joint tissue
resident memory T cells in the naïve joint that are phenotypically CD8+CD69+ and CD8+CD69+CD103+. We
hypothesize that the expression of PD-L1 by macrophages and/or T cells are essential for synovial
homeostasis and regulation of joint inflammation. In Aim 1, we will examine the importance of PD-L1
expression by synovial macrophages through the selective deletion of PD-L1 using the cre/flox system. We will
generate two macrophages specific PD-L1 KO mice, LyzcrePD-L1fl/fl and CD115crePD-L1fl/fl. We will induce CIA in
LyzcrePD-L1fl/fl, CD115crePD-L1fl/fl, Lyzcre and CD115cre mice and harvest the joint to determine the protective role
of synovial macrophage PD-L1 expression in CIA (Subaim 1.1). We will also perform parabiosis experiments by
surgically joining CD45.1 C57BL6 and CD45.2 CD115crePD-L1fl/fl to determine if PD-L1+ synovial macrophages
are resident or bone marrow derived during CIA (Subaim 1.2). We have found that PD-L1 is highly expressed
in synovial T cells. In Aim 2, we will examine the protective function of synovial T cells following CIA. We will use
LckcreP D-L1fl/fl mice, which lack PD-L1 expression in CD3+ T cells to examine the effects of PD-L1 specific
deletion in T cells during CIA (Subaim 2.1). To test if tissue resident memory T cells play a protective role during
CIA, we will utilize a tissue resident chimera mouse model to selectively delete peripheral T cells in LckcrePD-
L1fl/fl mice. Donor T cells from LckcrePD-L1fl/fl or Lckcre mice will replace peripheral T cell populations to confirm
the protective function of tissue resident memory T cells in the joint (Subaim 2.2). Our project has high
translational potential since joint specific PD-L1 expression could be modulated with therapeutic purposes in
humans for rheumatoid arthritis or check point inhibitors induced arthritis.

Public health relevance
Project Narrative This project will determine the importance of PD-L1 expression on macrophages and T cells within the joint during synovial inflammation during collagen induced arthritis. This will allow for more informed study into the treatment of immune related adverse events due to checkpoint inhibitor treatment and rheumatoid arthritis.